RESEARCH EDUCATION PROGRAM IN ASPECTS OF STATISTICAL GENETICS AND ADDICTION

DESCRIPTION (provided by applicant): This application seeks five years of support to develop, evaluate and fine-tune a new research education program (WU-STAGEM: Washington University Statistical Training in Addiction Genetics Methodology), to train postdoctoral level scientists (9 over the 5-year funding period). Trainees (program participants) will include both US and foreign nationals, drawn from backgrounds such as biostatistics, mathematics, quantitative psychology and statistical genetics. We will provide trainees with both (i) the expertise to develop, test and apply new statistical and computational models to address genetics-based research problems in addiction, and (ii) sufficient training to allow participants to work collaboratively in multidisciplinary teams alongside basic and clinical researchers engaged in addiction research. Program postdoctoral scientists will train under the guidance of mentoring teams composed of (a) clinical researchers in addiction, (b) basic scientists and, most critically, (c) researchers with pertinent statistical or computational modeling expertise, with the support of individually tailored formal coursework. They will work with addiction geneticists at the host institution and elsewhere (e.g., through the NIDA Genetics Consortium) to identify and conduct research in areas where unique and urgently needed contributions to the field of addiction genetics can be made, producing products such as novel computer software, novel algorithms or approaches to statistical genetic analysis, to advance the field of addiction genetics. These priority areas will include (varying according to trainee backgrounds and interests and expert input): 1) incorporation of bioinformatics data in the statistical analysis and interpretation of GWAS data, 2) challenges in the combination of GWAS data across data-sets characterized by differing sampling schemes and somewhat different phenotypic assessments, and 3) modeling of genotype x environment interaction effects, and incorporation of consideration of GxE effects in efforts at gene-discovery. We will take advantage of existing data sets such as those at the NIDA Center for Genetic studies; zork.wustl.edu/nida/ and at dbGap, as well as more extensive data-sets associated with local investigators, in this training effort. Through infrastructure development and continuing evaluation efforts, building upon outstanding existing institutional strengths, we will seek to develop a self-sustaining program, drawing upon the wide-ranging expertise at Washington University that can supply highly trained experts in statistical and computational modeling to the field of addiction genetics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Licit and illicit drug dependence represents a considerable personal and public health burden. The important role of individual genetic vulnerability in contributing to addiction risk is well established. However, there is a critical shortage of investigators with expertise in statistical genetics and computational genomics working in addiction research, a need that this application seeks to address through its postdoctoral research education program. NARRATIVE Licit and illicit drug dependence represents a considerable personal and public health burden. The important role of individual genetic vulnerability in contributing to addiction risk is well established. However, there is a critical shortage of investigators with expertise in statistical genetics and computational genomics working in addiction research, a need that this application seeks to address through its postdoctoral research education program. __SpecificAimsTextDelimiter__ 1. Specific Aims: The specific aims of our proposed research education program are: 1.1. Program development Establish a program of research education for the purpose of training postdoctoral researchers ('program participants') in the development of innovative statistical and computational tools relevant to genetics-based research problems in addiction, by building a new subspecialty for addiction genetics onto educational opportunities already offered at Washington University through programs in the Divisions of Biostatistics, Biological and Biomedical Sciences, and Human Genetics, and through the new Institute of Public Health. A flexible curriculum will include a continuing seminar on challenges faced by addiction researchers and approaches for the development of new statistical and computational models for addiction genetics research (to be led by program faculty), and a formal course series on addiction nosology, epidemiology, genetics and cognitive neuroscience. Other NIH trainees with mentored scientist, or institutional (T32) or individual fellowship (F32) awards, as well as junior and senior addictions faculty, will also be encouraged to participate. These core courses will be supplemented by formal coursework from existing curricula tailored to the needs of individual trainees; but most importantly, by individual mentoring under a research apprenticeship model, by a primary mentor exert in statistical genetics or computational genomics, and other mentoring team co-mentors with pertinent clinical or basic science expertise. 1.1.1 Curriculum development and implementation: Engage faculty at Washington University, as well as visiting faculty, with relevant backgrounds in statistical or computational aspects of genetics or genomics, basic science, and clinical research on addiction, to team-teach the core courses, and mentor trainees. 1.2 Infrastructure Development: Establish committees for the administration and setting of priorities for WU- STAGEM (Internal Program Committee, Executive Committee, subcommittees for Recruitment and Career Development, and for Curriculum Development and Evaluation), and an External Advisory Committee, with highly qualified members, to develop an intellectual resource with which to identify the greatest needs and priorities relevant to genetics-based research problems in addiction, and the full array of institutional resources that can be brought into play to address these problems. 1.3. Recruitment: Recruit a pool of outstanding trainee participants, both foreign and domestic, at both entry and senior post-doctoral levels with relevant backgrounds (e.g., mathematics; computer science; statistical genetics; biostatistics; or quantitative psychology) who will gain in expertise in the development and application of new statistical methods and computational modeling in addiction genetics. 1.4 Research training and education: Provide these trainees with an individualized program of education, with mentoring from highly qualified mentors, researchers with independent funding, including a primary mentor and his/her team with experience in some aspect of statistical or computational tool development relevant to genetic addictions research, and secondary mentors with basic science and/or clinical science expertise in addiction genetics-related research, who will provide the trainee with data and engage him/her in new tool/methods development consistent with the program goals. 1.5 Program contributions to statistical and computational methods in addiction genetics: In consultation with local investigators and external investigators working in addiction genetics (e.g., NIDA genetics consortium investigators, international investigators), identify priority areas that are potential roadblocks to progress in addiction genetics. Depending upon the expertise of specific trainees recruited, important contributions are anticipated in the areas of 1) incorporation of bioinformatics data in the statistical analysis and interpretation of GWAS data, 2) meta-analytic or mega-analytic (i.e., combining respondents across multiple studies) approaches to gene discovery, 3) modeling of genotype x environment interaction effects (including potentially genotype x metagenome interaction effects). Statistical approaches, software, algorithms or tools that are developed will be shared freely with the scientific community, to accelerate the progress of addiction genetics research. 1.6 Program evaluation and refinement: Through formal evaluation procedures, to provide ongoing short- term as well as long-term program evaluation, to allow program refinement, in order to build a program that will be self-sustaining in the long-term.